REACH Center Developmental Core

PROJECT SUMMARY - DEVELOPMENTAL CORE
The Developmental Core aims to provide pilot funding, networking, and educational and training opportunities
to develop a multidisciplinary, community-engaged climate and health research workforce. The Core integrates
and cross-pollinates climate change research with public health research by distributing $80,000 annually
through a REACH Pilot Awards Program and sparking multi-disciplinary collaborations through a Student
Research Fellowship program. For the Pilot Awards, the Core will ensure a strong applicant pool, soliciting
innovative and significant proposals, implementing a competitive application review process, and engaging
pilot awardees in Center activities. The Student Research Fellowships will engage students from all three
academic institutional partners to work as a collaborative cohort on a project that addresses a non-academic
partner need and leverages big data to advance health-protective and equitable climate solutions. The
Developmental Core will also provide educational and networking activities that catalyze multidisciplinary and
cross-institutional collaboration in research on climate and health. The Core will offer educational activities,
including a journal club, workshops to promote improved team science, and trainings on geospatial datasets to
build an informed climate and health research workforce. The Core will also implement cross-institutional
networking activities including Annual Research Days, research seminars, a Climate and Health Connections
lunch series, scientific working groups focusing on shared interests among Center investigators, and
expanding clinical engagement and clinical research. It will foster a strong existing interdisciplinary network
and emerging collaborations in climate-health research grants linking several Center investigators. Finally, the
Developmental Core will ensure that climate and health research is responsive to topics arising from
government and community stakeholders, collaborating closely with the Community Engagement Core. This
will be accomplished by engaging government and community partners in Pilot Awards and by co-sponsoring
workshops with the Community Engagement Core to facilitate improved knowledge-to-action and community-
engaged research. The Developmental Core will deliver innovative approaches throughout the research design
and implementation phases by prioritizing community engagement and solution-oriented goals throughout all of
its research and educational activities. The ultimate goal is for REACH research projects to be co-generated by
community and policy stakeholders in partnership with Center investigators, thereby ensuring that the research
and its results are actionable and lead towards solutions to protect health from the hazards posed by climate
change.